Request for Dell PowerEdge XE9680 8x H100 NVIDIA GPU server

This request is for funds to purchase a Dell PowerEdge XE9680 8x H100 GPU server with NV-Link. The
instrument will be housed within the Center for Biologic Imaging (CBI) a large, centralized imaging facility/Center
serving the needs of NIH supported researchers across our campus and at institutions both local and across the
US. A focus of this research Center is to develop, implement and integrate both traditional and new optical imaging
approaches into modern biomedical research.
Data reconstruction and quantitation is an essential arm of our research product and is integrated into
experimental protocols from first conception. Over the last 6 years we have been increasingly involved in the
development of imaging platforms and development of data processing workflows that require significant compute
resources, primarily GPU, which far exceed the processing capabilities of desktop workstations. The center currently
houses a dedicated machine room with several petabytes of storage and HPC cluster with 2 NVIDIA K80 GPU
nodes. However, data acquisition has rapidly outpaced our ability to process it using the current infrastructure.
The biggest data producers for the Center are; 1: Ribbon scanning confocal, 2: light sheet tools for large
tissue samples (MesoSPIM) and 3: multi-photon microscopy. The data sets generated by these methods are
commonly between 10 and 100 terabytes in size and cannot be rationally processed with conventional computing
solutions (single GPU workstations) and truly require modern computational architecture. The device requested
here, a 8x H100 GPU server with NV-Link, is configured to meet these needs. To date, we have used shared HPC
resources to supplement our computational needs, but these resources are neither intended for nor appropriate to
use for our high-demand environment. At this point, we feel that there is a very compelling argument to build
rationally scaled local capability. The fundamental reasons are difficulty of data movement and the absolute variety
and scale of the projects we conduct in our center being outside the interests of these shared resources.
The scientific diet of the Center ranges from Tissue Organoids to Pulmonary Medicine, from Ocular Biology
to Tumor Biology or expanded tissues or entire organisms (such as zebra fish). Because of this it is very difficult to
define and describe the diversity of research projects that this infrastructure will be used for. Accordingly, we have
limited our application to several “major user” projects which produce large datasets from high-speed imaging
systems and have an outsized need for GPU resources. Research areas include Neuroscience, Pulmonary
Medicine, Viral Pathogenesis, Collagen in health and disease, and Imaging Technology development. Each of these
major users needs to contextualize molecular or cellular events in the context of the whole organ or organisms at
cellular resolution or better. As this involves highly anisotropic tissues, or complex/rare interactions, the questions
cannot be addressed outside the context of the whole organ. Each illustrates a clear need for the compute
capability/platform we are requesting.

Public health relevance
We request a modern high-performance NVIDIA H100 GPU server to be housed in the Center for Biologic Imaging at the University of Pittsburgh. The device will serve the advanced computational needs of a large and diverse NIH funded research community that relies on advanced imaging systems to make fundamental scientific inquiries. The server will accelerate acquisition of data and analysis for these user groups.